Interaction between adipose tissue and central clock via the splanchnic nerve pathway for regulation of energy balance

Obesity is a growing problem in the US, with veterans being at a higher risk of developing it along
with diabetes and other obesity-related conditions. Bariatric surgery is one of the most common
and effective invasive therapy offered to patients with severe obesity. Time-restricted feeding
(TRF) behavior is one of the popular and wide-spread non-invasive therapies used to induce
weight loss among patients and practitioners. Our research seeks to explore the role of the gut's
"splanchnic neuron fibers" in communicating signals between the adipose tissue- “clock” and the
brain- “clock” to activate thermogenesis in fat and determine how these therapies affect the
molecular clock to induce their effect on energy homeostasis. Previous studies have shown that
Roux-en-Y gastric bypass (RYGB) induces its metabolic effects by activating the splanchnic/
sympathetic nerve activity sub-serving the gut and mesentery to induce fat thermogenesis.
Selective denervation of this tract leads to complete loss of all RYGB-induced metabolic effects.
Similarly, TRF has been shown to induce an increase in efferent sympathetic splanchnic nerve
activity compared to ad libitum feeding and it can rescue the abnormal metabolic derangements
on energy expenditure in forebrain-specific bmal1 knock out mice. On the other hand, it was
recently found that TRF could not rescue the loss of fat thermogenesis that was observed in
adipose tissue-deficient clock. This data suggests that the molecular clock in adipose tissue and
brain play a key role in energy homeostasis and communicate through afferent splanchnic
neurons to activate efferent splanchnic neurons serving the mesentery and white adipose tissue
to induce fat thermogenesis. The aim of this study is to explore the role of clock machinery in
controlling energy homeostasis following TRF and RYGB and the requirement of the splanchnic
nerve fibers in this regulation . Aim #1 will examine the capacity of peripheral clock within fat
tissue to regulate afferent splanchnic nerve activity and its role in regulating energy balance during
TRF and RYGB. Aim #2 will assess the ability of forebrain-specific clock machinery in regulating
efferent splanchnic activity and subsequently fat thermogenesis in the setting of TRF and RYGB.
Identifying the neuronal and neuro-molecular pathways used by both RYGB and TRF to induce
their metabolic effects could lead to the development of novel treatments for obesity. By
understanding how the molecular clock in the adipose tissue and brain regulates energy
homeostasis in response to RYGB and TRF, it may be possible to develop more effective, and
less invasive therapies for obesity.

Public health relevance
Obesity and diabetes are recognizably more prevalent among US Veterans than general population placing making them at higher overall risk for death from cardiovascular diseases and cancer. A disrupted circadian behavior, such irregular sleep-wake cycles or night eating syndrome disrupts the molecular clock rhythm and increases the risk for insulin resistance and obesity; nevertheless, correction of this circadian disruption re- synchronizes the clock machinery with the host’s normal behavior and corrects the metabolic abnormalities. This project will test the novel hypothesis projecting that the molecular clock in fat tissues crosstalk with brain clock v i a the splanchnic nerve (subserving the mesenteric gut) to induce the “previously proven” thermogenic effects of time-restricted feeding (TRF) and gastric bypass surgery (RYGB). Understanding the underlying mechanisms by which the molecular clock in adipose tissue and brain regulates energy during TRF and RYGB, will hopefully lead to more effective and less invasive obesity therapies.